High-Resolution Tandem Mass Spectrometer to Support Large Molecule Structural Characterization

Project Summary/Abstract
A unique state-of-the-art hybrid high-resolution tandem mass spectrometer equipped with electrospray ionization
(ESI) and a variety of activation/dissociation methods for structural characterization of a broad range of large
biological and synthetic molecules is requested. This instrument will be a vital component to advance the
research aims of over 11 NIH-supported projects. The studies involve a variety of biomolecule structure related
research, including the characterization of protein-protein and protein-ligand (metals, lipids, inhibitors, co-factors)
interactions, membrane proteins and their interactions with lipids, protein aggregates, therapeutics, RNA-
inhibitor complexes, and protein-bioconjugated molecules. The research projects impact a range of human
health issues, including neurodegenerative diseases, such as Alzheimer’s and Parkinson’s diseases, bacterial
infectious diseases, hypertrophic cardiomyopathy, cancer, oral cavity infections, and viral infections. The high-
resolution mass spectrometer will be capable of low-parts-per-million mass measurement accuracy for intact
biomolecules and product ions derived from tandem mass spectrometry (MS/MS) experiments. It will have
capabilities for multistage MS-n experiments (where n is greater than 2), thus permitting advanced top-down MS
analysis using collision-, electron-, and photon-based fragmentation methods for efficient ion activation and
dissociation. Access to multiple fragmentation methods on the same instrument greatly improves the ability to
dissociate large intact biomolecules to derive complete sequence/structure information, as well as the direct
detection of posttranslational modifications and proteoforms. The proposed high-resolution tandem mass
spectrometry system will be supported and administered by the UCLA Molecular Instrumentation Center (MIC),
a campus-wide, integrated facility formed to enhance the accessibility of existing shared, sophisticated
instrumentation facilities to the broader research community at the institution.

Public health relevance
Project Narrative The new instrumentation will benefit a wide range of biomedical and structural biology studies. The high sensitivity and high resolution capabilities of the system will provide a new means to identify the mechanistic basis of a number of human diseases, such as neurodegenerative disorders, and it may be used to identify new drug targets and therapeutic molecules.